Prevention of LUTS: Bladder Health Clinical Center, UC San Diego Site

PROJECT SUMMARY/ABSTRACT
The Prevention of Lower Urinary Tract Symptoms (PLUS) Consortium was established to lay the foundation
necessary to study bladder health (BH) in women and girls, including the identification of risk and protective
factors for BH using a longitudinal cohort. Factors identified across the spectrum of the PLUS conceptual
model, from societal to biologic, will establish the evidence base for intervention studies designed by PLUS
researchers and others in the field. The objective of this application is to present the UC San Diego Clinical
Research Center (CRC) as a diverse, experienced, committed, and invaluable contributor to the Consortium.
We will continue to provide the unique transdisciplinary expertise necessary for the Consortium to advance the
study and promotion of BH. Members of our team have extensive experience in transdisciplinary research,
epidemiology, longitudinal cohort studies, prevention science, public health, health education, cross cultural
research, qualitative research, primary care (Pediatrics, Obstetrics & Gynecology), clinical care of women with
LUTS, and are world renown for population-based microbiome research. We boast a history of strong
leadership and critical contributions to the foundational work of the Consortium, including leadership in the
development and validation of instruments for BH and qualitative research on the Study of Habits, Attitudes,
Realities and Experiences (SHARE) and related knowledge, attitudes and beliefs (KAB). UC San Diego is a
well-established research institution, funded by the National Institutes of Health, including a sponsored Clinical
& Translational Science Award which provides a full spectrum of resources and personnel for the conduct of
basic science, translational, epidemiologic, behavioral, and clinical research across the full age spectrum
among racially and ethnically diverse communities. In addition to the foundational work of validating the
bladder health instrument (BHI) for use in a culturally diverse population, our proposal incorporates cutting
edge translational research aimed at identifying a healthy urogenital microbiome. The unique strengths of our
application include: a) robust contributions to the foundational work of the Consortium including two team
members actively engaged in the design of the planned longitudinal cohort study; b) a history of strong
recruitment and retention of ethnically diverse participants for qualitative (SHARE), quantitative clinical trials
and longitudinal cohort studies; c) a conceptual model centered around the notion that BH may be mediated
through societal, institutional, interpersonal, behavioral and biologic factors via the urogenital microbiome; d) a
feasibility pilot study of collection and analysis of voided urine specimens from a longitudinal cohort, which will
foster investigations of prevention studies that manipulate the urogenital microbiome (directly or indirectly)
through changes in modifiable risk factors across the PLUS conceptual framework; and e) the development of
new measures for use in linguistically and culturally diverse populations starting with an adapted and validated
Hispanic (English and Spanish language) BHI and KAB questionnaire.

Public health relevance
PROJECT NARRATIVE Lower urinary tract symptoms (LUTS) affect millions of women and girls, have a major negative impact on quality of life, and are a source of economic burden. The majority of individuals with LUTS do not seek care; thus, to decrease suffering and health care costs, a shift towards the study of bladder health (BH) is urgently needed. Our approach will assess risk and protective factors related to BH using qualitative and quantitative methods and determine if the urogenital microbiome is a viable target for future prevention studies.